Chip NMR biosensor for molecular analysis of cells

DESCRIPTION (provided by applicant): One of the major challenges in medicine is the rapid and accurate measurement of protein bio- markers, cells and organisms in different biological samples. During the prior funding period we had developed a broadly applicable, novel, point-of-care diagnostic platform using magnetic relaxation switches as a proximity sensor to amplify molecular interactions. We have shown that highly sensitive and selective measurements (e.g. DNA, mRNA, proteins, metabolites, drugs, bacteria, cells) can be obtained on small volume of unprocessed biological samples. One of the critical limitations of the approach however, was the need for bulky and/or complex NMR systems to carry out the measurements. We have now achieved a technological breakthrough by miniaturizing an entire NMR system onto a single, integrated circuit (IC) chip (dubbed DMR for diagnostic magnetic resonance). In preliminary feasibility experiments, we have shown that we can already achieve detection sensitivities of 10-12 M surpassing those of many traditional, time consuming assays. The goal of this competing renewal is to further mature DMR into a cutting-edge detection technology and apply it to molecular and cellular sensing and profiling of cells. Using cancer cells as a specific sensing target, we propose three specific aims to refine and further validate the DMR technology: 1) optimize particle constructs for high efficiency detection of cancer cells; 2) determine the detection threshold and specificity for cancer cells and 3) develop real time molecular analysis of cells in biological samples. This proposal addresses a number of unmet needs and aims at optimizing, validating and further improving the novel DMR biodetection platform. PUBLIC HEALTH RELEVANCE: We are developing a handheld sensor to quickly assay blood and tissue samples in cancer patients. Based on fundamentally new designs, this technology allows sensing and rapid profiling of cancer cells in blood.

Public health relevance
We are developing a handheld sensor to quickly assay blood and tissue samples in cancer patients. Based on fundamentally new designs, this technology allows sensing and rapid profiling of cancer cells in blood.